Novel Therapeutics for Opioid Use Disorder in the Acute Overdose and Maintenance Settings

Abstract
Opioid drugs like morphine, codeine, and fentanyl confer life-saving analgesia for millions, enabling
otherwise impossible medical interventions. These benefits are offset by dose limiting liabilities, including
respiratory depression - the cause of all opioid deaths - and opioid use disorder (OUD). OUD reflects a cycle of
increasing use, dependence, and withdrawal that eventually triggers a respiratory crisis. The CDC estimates that
72,000 Americans died in opioid overdose last year, the leading cause of death in adults under 50.
Many of these deaths arise from overdoses (OD) of potent opioids like fentanyl and carfentanyl. While
naloxone can restore breathing, its short half-life requires multiple administrations to reverse OD, and may
result in relapse after initial reversal, as naloxone is eliminated while the illicit drug persists. Further, the anguish
of precipitated withdrawal prompts rapid, and exceedingly dangerous, return to drug-seeking. Beyond OD
reversal, the standard of care in OUD is maintenance treatment with agonists buprenorphine and methadone.
Both reduce relapses and mortality, but access and adoption are limited by dosage forms, metabolic liabilities,
and potential for abuse and diversion. Better medicines for overdose reversal and for OUD maintenance are
urgently needed.
Here we develop chemically novel, potent mu-opioid receptor (MOR) antagonists, low- and mid-efficacy
partial agonists. Our current lead counds can outcompete opioid overdoses in preclinical models with a longer
half-life, a key naloxone liability. The potent, low-efficacy partial agonists add a low opioid tone, diminishing
the aversive effects of pure antagonists. These, and the mid-efficacy partial agonists, are leads to maintenance
therapeutics for OUD.

Public health relevance
Narrative Opioid use disorder reflects a cycle of increasing use, dependence, and withdrawal that eventually triggers a respiratory crisis. Many of these deaths arise from overdoses of potent opioids like fentanyl and carfentanyl. Here we aim to develop new therapeutics that can outcompete opioid overdoses due to fentanyl and carfentanyl and could be used in the overdose and maintenance settings, starting from our promising proprietary lead compounds.